Watson Phase I COBRE Research Core

RESEARCH CORE PROJECT SUMMARY / ABSTRACT
The Center of Biomedical Research Excellence in Multiscale Biomolecular Sensing (MBS) will unite experts in
biology, biochemistry, chemistry, spectroscopy, materials science, and biomedical engineering to develop novel
mechanisms and tools for sensing of biochemical and biological processes that will directly impact a wide range
of human diseases. Biomolecular sensing research spans the continuum from molecular to cellular to organismal
scales, necessitating diverse tools and equipment to investigate and develop innovative biomolecular sensing
platforms. Recognizing these needs, and utilizing exceptional levels of institutional commitment, the MBS will
build a state-of-the-art Research Core that will include three distinct subcores and transcend these research
scales. We will also expand computational resources that will support research within the MBS.
The Core will be led by an internationally recognized scientist with extensive experience in instrumentation and
building of Core labs. This Core director will be supported by a Lead Scientist and other staff who will oversee
instrumentation and equipment within the Core. A Research Core Advisory Committee of both UD and external
experts from local industry will help rigorously guide the success of the Research Core. The core is innovative
by design, bringing unique, high throughput workflows to the academic setting and CRISPR/Cas9/microinjection
techniques to our IDeA State in the Transgenic Mouse Subcore. Specifically, we will:
Aim 1: Develop and Support a High Throughput Chromatography and Experimentation Subcore.
Aim 2: Develop and Support a Biophysical Subcore.
Aim 3: Develop and Support a Transgenic Mouse Subcore (the first in the State of Delaware).
Aim 4: Expand Existing COBRE Computational Research Cluster.
Success of the MBS Research Core will bring new, unique, and needed research capabilities to the University
of Delaware, which will not only enable the Research Projects of the MBS, but will also benefit the NIH-funded
biomedical research broadly across the State of Delaware.

Public health relevance
PROJECT NARRATIVE Project Narrative is not required in this component